Cancer Center Support Grant

Project Summary/Abstract: Overall
The Norris Cotton Cancer Center (NCCC) is responsible for overseeing all cancer-related academic and
clinical activities across the entirety of Dartmouth College and the Dartmouth-Hitchcock (D-H) health system,
as evidenced by 123 Members spanning 4 Schools and 24 Departments and NCCC-initiated research
infrastructure adopted campus-wide. In the current application, we summarize research accomplishments and
document fulfillment of the NCI’s Six Essential Characteristics for NCI-Designated Centers. The mission of
NCCC is to accelerate trans-disciplinary research to prevent and cure cancer, enhance survivorship, and
promote health equity, evident in significant funded patient-centric population science and diversity-focused
engagement of trainees across the education continuum. Reflecting deep integration within our host
institutions, NCCC is comprised of four truly trans-disciplinary research programs, reflecting active NCCC
Planning & Evaluation: Immunology and Cancer Immunotherapy (ICI); Translational Engineering in Cancer
(TEC); Cancer Biology and Therapeutics (CBT); and Cancer Population Sciences (CPS). Included in our
research portfolio are groundbreaking scientific initiatives in cancer immunology, cancer engineering, biological
mechanisms, experimental therapeutics, molecular epidemiology, health care delivery science and cancer
prevention and control, with an enhanced emphasis on translating research discoveries to hard-to-reach
populations, especially those within our rural two-state catchment area of New Hampshire and Vermont. NCCC
continues to be defined by its high impact scientific publications and the frequency with which they are enabled
by Cancer Center support of trans-disciplinary research, as evidenced by inter- (31%) and intra-(17%) co-
authorships, cancer themes in IDeA-funded program projects, and access to NCCC Shared Resources that
include several (e.g., Pathology, Trace Elements, Genomics) relied upon widely by other NCI designated
centers. Consistent with our commitment to both high quality science and the successful translation of
research discoveries to the clinic, the past five years have witnessed an 18% increase in our NIH-funded
research portfolio, including a >7:1 return on Developmental Funds, and a 62% increase in clinical trials
accrual, including funding as an NCTN lead participation site. Depth of Leadership was evidenced by
accomplishments during a recent Director transition. Shortly following the September 2017 arrival of Dr. Steven
Leach as Center Director, NCCC embarked upon a new 2018 Strategic Plan, which identified accelerating
translational and trans-disciplinary research as our single highest overarching strategic priority. Emanating
from this plan and enabled by a dramatic increase in investment from our parent institutions, in this application
we further document the launch of multiple new initiatives in faculty recruitment (8 completed in 2017-2018, 3
active, and 2 pending), faculty research support, education and community outreach, serving to propel a
comprehensive NCCC into its fifth decade of NCI designation.

Public health relevance
Project Narrative Among the fifty states, New Hampshire ranks number one in the incidence of breast, esophageal, and urinary bladder cancers, the latter reflecting the association between bladder cancer and environmental arsenic exposure linked to frequent use of rural well water within the “Granite State”. Of similar concern, Vermont ranks number one in the incidence of uterine cancer and second in the incidence of melanoma. Norris Cotton Cancer Center continues to create important new knowledge, engage our community, and influence public policy related to these and other cancers in a manner directly relevant to these unique catchment area public health needs.